Research and mentoring on cognitive neuroscience and high-field MRI of the thalamus in schizophrenia

ABSTRACT
A K24 Mid-Career Investigator Award in Patient-Oriented Research (POR) is requested to: 1) augment my
capabilities in POR to include new expertise in network science, and the cognitive neuroscience and
neuroimaging of the human thalamus; 2) apply these new expertise to perform novel studies of thalamic
connectivity, function, and structure in psychotic disorders; and 3) enhance my mentorship skills and provide
protected time to mentor trainees. My research program investigating the neural basis of psychotic disorders
serves as a platform for training POR trainees. This includes mentoring junior faculty, postdoctoral fellows,
graduate students, and MD/PhD medical students in psychotic disorders, neuroimaging, and neuropsychology.
For the past several years my lab has focused on investigating thalamocortical circuit abnormalities in
psychotic disorders. We were among the first to show that functional connectivity of the thalamus in
schizophrenia is characterized by a combination of lower connectivity with the prefrontal cortex (PFC) and
hyper-connectivity with sensorimotor cortical areas. Our findings coincided with groundbreaking discoveries in
the cognitive neuroscience of the thalamus. However, many recent advances in the fundamental neuroscience
of the thalamus have yet to translate to improved understanding of the mechanisms of psychosis phenotypes.
This translational gap is impeding progress in identifying potential treatment targets for cognitive impairment.
Progress is further hindered by limitations of conventional neuroimaging methods which are unable to directly
visualize individual thalamic nuclei in humans. This proposal provides the foundation for addressing these
challenges. Specifically, I will develop new research skills in network science (Aim 1) and the cognitive
neuroscience of the thalamus (Aim 2A), extend existing expertise in neuroimaging to include state-of-the-art
methods for imaging the human thalamus in vivo (Aim 2B), and apply these new expertise to characterize
thalamic nuclei structure and function abnormalities in early stage schizophrenia (Aim 3). This proposal will: 1)
enhance ongoing work in my lab characterizing brain connectivity in psychopathology and normal cognitive
development; and 2) provide me with critical expertise required for future studies focused on informing
thalamocortical mechanisms of psychosis phenotypes.

Public health relevance
Public Health Relevance: Schizophrenia is a debilitating illness that results in life-long limitations in psychosocial functioning, significant caregiver burden, and over $150 billion a year in economic costs. This proposal will use methods from network science, cognitive neuroscience, and neuroimaging to characterize thalamocortical circuit dysfunction in schizophrenia. Understanding the neural basis of schizophrenia is essential to developing new treatments for the disorder.